Cooperation of Co-Amplified Genes in Hepatocellular Carcinoma

PROJECT 2: SUMMARY
Hepatocellular carcinoma (HCC) is a highly fatal disease with an alarming increase in incidence and mortality.
Obesity-induced non-alcoholic steatohepatitis (NASH) is a leading cause of HCC. Immune checkpoint
inhibitors (ICIs) have been approved for HCC treatment, but patients with HCC and underlying NASH (NASH-
HCC) do not respond as well to ICIs. The lack of effective treatment for advanced HCC mandates that novel
players regulating HCC be identified that might be targeted to develop effective combinatorial therapies. The
oncogene MYC plays a key role in the development and progression of HCC, including NASH-HCC, and the
MYC gene is frequently amplified in HCC patients. TATA-box binding protein associated factor 2 (TAF2) gene
shows the highest co-amplification with MYC. As yet, there are no studies analyzing the role of TAF2 in cancer,
including HCC. Our preliminary studies unravel overexpression of TAF2 in human HCC and a significantly
strong negative correlation between TAF2 expression levels and HCC patient survival. In mouse liver,
overexpression of MYC alone induced HCC with a variable degree; TAF2 alone did not induce tumors, but the
combination of TAF2 and MYC generated robust HCC, indicating that these co-amplified genes cooperate to
promote aggressive HCC. Interaction was observed between MYC and TAF2, and RNA-sequencing revealed
significant modulation of MYC-mediated gene regulation upon TAF2 overexpression. TAF2 knockdown in
human HCC cells profoundly inhibited migration and invasion, and a hepatocyte-targeted nanoparticle
delivering TAF2 siRNA inhibited mouse HCC allografts in syngeneic mice. Interestingly, knocking down TAF2
in human HCC cells conferred increased susceptibility to MYCi975, a specific MYC inhibitor that synergistically
enhances ICI efficacy. Based on these findings, it is hypothesized that 1) as transcriptional regulators, MYC
and TAF2 cooperate to promote HCC by inducing a global change in transcription, 2) TAF2 is required for the
maintenance of HCC, and 3) combined inhibition of MYC and TAF2 augments ICI therapeutic efficacy, thus
serving as an efficient way to counteract HCC. These hypotheses will be interrogated by investigating the
molecular mechanism by which MYC and TAF2 promote HCC and the role of TAF2 during HCC development
and progression using a conditional TAF2 knockout mouse, and by evaluating combined inhibition of MYC and
TAF2 along with ICI as a therapeutic strategy in endogenous mouse models of HCC and NASH-HCC. This
proposal is innovative and has important mechanistic and translational significance with the potential to affect
survival for scores of patients with HCC.

Public health relevance
PROJECT 2: NARRATIVE The proposed studies will interrogate the mechanism by which two co-amplified genes, MYC and TAF2, cooperate to promote hepatocellular carcinoma (HCC) development and progression and evaluate therapeutic efficacy of combined inhibition of MYC and TAF2 along with immune checkpoint inhibitors in endogenous mouse models of HCC.